Neurogenic bone loss after SCI: skeletal rehabilitation via Wnt and exercise interactions

The purpose of this application is to identify a long-term rehabilitative solution to skeletal fragility associated
with spinal cord injury (SCI). SCI is one of the most debilitating medical conditions among the veteran
population. Neurogenic osteopenia is a major complicating factor for SCI rehabilitation efforts, and there is
currently a paucity of options for treating bone wasting associated with SCI. Thus, an urgent need exists to
develop new rehabilitative strategies for preserving and/or restoring bone lost to SCI. This is particularly true
given that significant advances are being made in neuromuscular rehabilitation (e.g., harnessing motoneuron
plasticity and sprouting/regeneration mechanisms) for functional restoration; all of those efforts are in jeopardy
if they are not accompanied by restoration of bone structure and strength, as fractures can nullify progress
made in neurological rehabilitation. Although neurogenic bone loss is a different disease than standard
postmenopausal osteoporosis (PMO) or senile osteoporosis, there are no approved therapies that specifically
target the sequelae of SCI-induced bone loss. The closest drug option for SCI-induced bone loss is the
sclerostin neutralizing antibody Romosozumab (“Romo”), due to its potent anabolic action and efficacy in
mouse models of SCI. However, Romo received a black box warning from the FDA cautioning its use in
patients at higher risk for cardiovascular disease and stroke, two risk factors that are significantly elevated in
SCI patients. Therefore, while the bone-building effects of Romo are beneficial in SCI, its use at full strength is
not suitable for SCI patients. We have found a combination therapy (sclerostin and Dkk1 neutralization) that
reduces the sclerostin antibody dose by 83% (and total drug dose by 75%) yet still maintains all of the
osteoanabolic action of full strength sclerostin antibody. Our overall goal is to is capitalize on the interaction
between a very specific and novel osteoanabolic therapy (identified in our lab), and the powerful, lasting effects
of mechanical stimulation (exercise), to define a rehabilitative strategy for neurogenic bone loss that will have
lasting effects beyond the short-lived windows of most pharmaceutical options. Our approach takes into
consideration the risk factors associated with SCI (e.g., elevated cardiovascular complications and stroke) and
the beneficial effects of exercise to both the skeleton and to motor function to design a more tailored and
focused approach to skeletal rehabilitation after SCI. In the first aim, we will determine whether an optimized
ratio of sclerostin/Dkk1 antibody treatment can restore skeletal density, size, and strength after neurogenic
bone loss from SCI. In the second aim, we will determine whether optimized sclerostin/Dkk1 antibody
treatment can sensitize bone to the effects of mechanical exercise after SCI, producing a more robust and
fracture-resistant skeleton. In the third aim, we will determine whether continued mechanical stimulation can
maintain the beneficial skeletal effects of discontinued sclerostin/Dkk1 antibody treatment, ultimately providing
a long-term, non-pharmacologic solution to skeletal maintenance after SCI. We will simultaneously assess
motoneuron and skeletal muscle recovery, and functional/behavioral outcomes to evaluate the effect of the
therapy on neuronal and muscle recovery. As (1) the activation of Wnt signaling and (2) exercise are both
therapeutic for axonal regeneration, myogenesis, and skeletal health, the approach we propose is likely to
have multi-systems benefit in SCI patients.

Public health relevance
Traumatic spinal cord injury (SCI) is among the most disabling conditions affecting wounded members of the U.S. military. In 2017 there were more than a quarter million documented SCI cases in the US, 17% of which were among veterans. Although survival rates associated with SCI remain high, the life-altering nature of these injuries leads to significant loss of mobility and independence. So-called “secondary conditions” of SCI can be equally devastating. For example, SCI induces rapid and extensive sub-lesional bone loss and bone wasting is around 10 times more severe than the bone loss seen among postmenopausal osteoporosis patients. As a consequence, fracture risk is increased dramatically among SCI patients. Clearly, there is a need to address neurogenic bone loss associated with SCI, so that rehabilitation across multiple systems and tissues can be more effective, and improved quality of life can be achieved for our veterans with SCI.